Medical Mentorship: Building Pathways to Health Careers

Hopa Mountain, working in partnership with Montana State University’s WWAMI Medical School, will launch a Medical Mentorship program for students interested in pursuing careers in medicine. The goal of this initiative is to increase the number of students who seek careers in medical and health-related fields, ultimately improving their communities. Medical Mentorship will have meaningful impacts annually through three strategies: (1) Year-round college preparation programs for 250 teens to explore health career options; (2) Medical Mentorship: Food as Health materials and programs for 2,000 children and families; and (3) Professional development for 200 educators, community members, and parents. The overall goal of the Medical Mentorship program is to support student interest in and exposure to careers in the biomedical and health sciences.

Public health relevance
The Medical Mentorship program will create a stronger workforce and will help more Montana students to pursue careers in the health sciences. Montana families and children will benefit from new Food as Health food kits and learning materials as they highlight important health practices like nutritious eating and exercise.